Chemistry-Biochemistry-Biology Interface (CBBI) Program at Notre Dame

Abstract
The Chemistry-Biochemistry-Biology Interface (CBBI) Program at the University of Notre Dame is an
established NIH-funded program that supports the training of diverse pool of scientists who conduct
multidisciplinary research at the interface of chemistry and biology-related disciplines. The goal of the CBBI
Program is to produce PhD scientists who work effectively at the interface of chemistry and biology and who are
able to speak the language of two or more disciplines. The CBBI Program has established an outstanding training
environment for our predoctoral trainees. Since 2007 we have trained 84 students, 57 of whom have completed
PhD degrees in an average of 5.14 years (time to PhD degree from CBBI trainees is 4.98 in the past 10 years)
with 19 still in training. Of these 84, 16 are underrepresented minorities (URMs), 10 of whom have already
received PhD degrees. Our 84 trainees have 362 publications, of which 159 are first-author publications. This
represents 4.3 publications per trainee and 1.9 first-author publications per trainee. The 16 URMs have produced
79 publications, of which 31 are first-author publications; this represents 4.9 publications per URM and 1.9 first-
author publications per URM. During the past 14 years, our attrition rate has been low, with only eight of 84
trainees (9.5%) who did not complete a PhD degree. The key highlights of the CBBI Program are: 1) a large and
diverse pool of highly qualified candidates; 2) a strong track record of collaborative and multidisciplinary research
by both trainees and mentors; 3) a diverse faculty group that serves as research mentors and are experienced,
productive, and federally-funded; 4) an intensive, cross-disciplinary research internship in the other field outside
the mentor’s laboratory; 5) multidisciplinary seminars that supplement training; 6) individual and group meetings
with trainees; 7) the annual CBBI symposium that features both oral and poster presentations at the chemistry-
biology interface; 8) program administration with an established track record of training students at the chemistry-
biology interface; 9) a plan and mechanism for continuous evaluation and refinement of the training program;
10) professional development and career placement; 11) outstanding research facilities; and 12) a strong
institutional commitment. We propose to continue to train PhD scientists with the skills and expertise to solve
challenging biomedical problems, regardless of discipline. The University of Notre Dame enthusiastically
supports this training program, and will continue to provide a generous fellowship match to the CBBI Program
and additional resources, including the cost of the research internship for all trainees, upon renewal of funding
by the NIH.

Public health relevance
Project Narrative State-of-the-art biomedical research is highly multidisciplinary, requiring contributions from a diverse group of researchers. The Chemistry-Biochemistry-Biology Interface (CBBI) Program at the University of Notre Dame has met the challenge for cross-disciplinary training and has produced researchers with a synergistic combination of highly rigorous scientific skills, a broad knowledge base across both chemistry and biological disciplines, and excellent communication skills. Our goal is to continue to train PhD scientists with the skillsets and knowledge to solve challenging and significant biomedical problems, regardless of discipline.